The functions of the claustrum in flexible decision making.

PROJECT SUMMARY:
Cognitive flexibility is disrupted in many neuropsychiatric diseases, but how the brain generates flexible
behavior is not fully understood. Learning from recent actions requires neural mechanisms that maintain
information about relevant decision variables to influence future decisions. Persistent activity in cortical areas
required for cognitive flexibility, such as prefrontal cortex (PFC), connect an animal's choices and recent
outcomes. Neural mechanisms for generating and maintaining this persistent activity involve excitatory loops
between the neocortex and subcortical structures. Recent studies suggest that the claustrum, a poorly
understood subcortical nucleus that forms reciprocal connections with the neocortex, is particularly highly
interconnected with cortical areas strongly implicated in behavioral flexibility. We propose to test whether the
claustrum contributes to generating flexible behaviors using two tasks, dynamic foraging and reversal learning.
These tasks require medial prefrontal cortex (mPFC) and lateral orbitofrontal cortex (lOFC) function
respectively, two areas likely influenced by claustrum activity based on recent studies of claustro-cortical-
claustral loops. First, we will test the hypothesis that the activity of claustrum neurons encodes decision
variables in these two tasks. Second, we will determine whether claustrocortical neurons are required for
dynamic decision making and reversal learning, respectively. In addition, we will test whether claustrocortical
projections contribute to generating persistent cortical activity and influence the encoding of decision variables
by cortical neurons. We will further test whether claustrocortical neurons with projections biased to two different
cortical areas, Cla→mPFC and Cla→lOFC neurons, form distinct functional modules within the claustrum and
whether the claustrocortical projections to mPFC and lOFC influence cortical activity using similar cellular
mechanisms. Third, we will test whether claustrocortical projections are required for learning at different
timescales, both during and after the acquisition of a reversal learning task. We predict that claustrocortical
loops contribute to generating and maintaining persistent activity in the cortex required for task performance
and learning at multiple timescales. Together, these data will represent the first studies of claustrum neurons in
well established, carefully controlled, decision-making tasks combined with quantitative models using
normative theory. Furthermore, these experiments will directly test effects of claustrocortical inputs on an
animal's responses and on cortical activity during flexible behavior, enabling the integration of the
claustrocortical system into models of flexible decision making and cognitive control in health and disease.

Public health relevance
Project narrative: Cognitive flexibility is disrupted in many neuropsychiatric diseases, but how the brain generates flexible behavior remains a fundamental unanswered question in neuroscience. We will test whether interactions between the cerebral cortex and the claustrum, an enigmatic subcortical brain structure highly interconnected with cortical areas implicated in behavioral flexibility, contribute to decision- making and learning across different timescales. These experiments are important for understanding a central aspect of mammalian behavior, cognitive flexibility, which is impaired in psychiatric diseases like schizophrenia, attention-deficit/hyperactivity disorder and autism.